DIAGNOSTIC YIELD OF LOOP MONITORS IN SYNCOPE OF UNKNOWN ORIGIN

The purpose of this study is to define the incremental diagnostic yield of cardiac loop ECG recorders over Holter monitors in patients with unexplained syncope.